Genome Editing Therapy for Usher Syndrome Type 3

PROJECT SUMMARY/ABSTRACT
Usher syndrome type 3A (USH3A), an autosomal recessive disorder, is characterized by progressive
loss of hearing and vision due to a clarin-1 (CLRN1) gene mutation. A person with type 3 Usher syndrome will
usually require cochlea implants by mid- to late adulthood and classified as being legally blind. The
management of the chronic, progressive, severe vision loss (retinitis pigmentosa, RP) in USH3A remains a
challenge. CLRN1 expression in retina is finely regulated. AAV delivered gene augmentation therapy has
shown efficacy in the inner ear of USH3A mice but shown detrimental effects on retinal function in wildtype
mice, indicating the right combination of AAV vector dose, promoter, and delivery method needs to be well
optimized to develop a safe gene therapy for USH3A RP. However, the expression level of AAV delivered
gene expression is hard to control and is subject to gene silencing over time. The alternative approach of gene
editing therapy can directly repair a defective gene in the genome, result in expression under endogenous
regulatory element control, and may provide a promising therapeutic strategy for treatment of USH3A RP and
other genetic eye disorders. Current gene editing tools suffer from off-target safety concerns and low repair
efficiency. In 2020, our group reported a novel Cas9 variant, known as meticulous integration Cas9 (miCas9),
with improved knock-in (KI) efficiency and dramatically reduced undesirable on- and off-target
insertion/deletion events (indels). We believe the use of miCas9 strategy will provide the safety and efficacy to
enable the CLRN1 gene correction in the retina.
The lack of clinically relevant animal models is the bottleneck to developing effective therapeutics for
RP in USH3A. The rabbit is a classic model to study eye diseases. We recently developed rabbit models
carrying the CLRN1 frameshift (CLRN1−/−) and the CLRN1N48K/N48K point mutation. Preliminary characterization
of these rabbits has shown that CLRN1 mutations lead to severe progressive vision and hearing degeneration.
To our knowledge these are the first USH3A translational animal models that convincingly recapitulates the
progressive vision and hearing degeneration phenotype.
In this STTR FAST TRACK application, taking advantage of the novel miCas9 tools and the novel
rabbit models we have established, we propose to develop a gene editing therapy to treat vision loss in
USH3A. In Phase1, we will characterize the eye phenotypes of the CLRN1N48K/N48K rabbits(aim1) and develop a
miCas9 mediated hCLRN1 cDNA targeted integration strategy that fit for all CLRN1 mutations(aim2). Through
this Phase I work, we will establish the feasibility of gene editing in the USH3A rabbit retina. In Phase II work,
we will test the safety and efficacy of this USH3A gene editing therapy in our USH3A rabbit model through
subretinal injection, to provide the preclinical evidence of miCas9 mediated USH3A gene editing therapy. This
new knowledge has the potential to advance a first-in-class clinical treatment for Usher Syndrome Type 3A.

Public health relevance
PROJECT NARRATIVE Lack of a clinically relevant animal model restricted the development of therapeutics for Usher Syndrome Type 3A (USH3A). To address this challenge, we created a CLRN1 gene mutant rabbit model showing early onset, and progressive retina degeneration mimicking the Retinitis Pigmentosa symptoms in USH3A patients. Using our novel Cas9 variant (miCas9), known to show lower off-target effects and higher KI efficiency, in this rabbit model, we propose to evaluate a gene editing therapy in the eye for USH3A by insertion of the coding region of the clarin1 gene after its natural promoter to treat any causative clarin1 mutation, potentially altering the progressive vision loss that occurs with this disease.